STUDY OF LAZABEMIDE IN PATIENTS WITH ALZHEIMER'S DISEASE

This study will characterize the dose response, safety and efficacy of lazabemide in patients with Alzheimer's disease, using neurologic and functional parameters for assessment.